Control of gene expression via RNA-targeted covalent probes

Project Summary
RNA is now recognized as a compelling therapeutic target because it lies upstream of all protein function and
has cellular roles that go beyond protein translation. Similar to proteins, RNA molecules can fold to create
complex tertiary structures that form binding pockets capable of specific small-molecule engagement.
However, compared to proteins, few small molecules have been rationally designed to target RNA. The central
challenges to developing RNA-targeting ligands are, first, the difficulty of identifying ligandable sites on RNA
and, second, the lack of direct strategies for converting ligand binding into functional perturbation of mRNA
stability, translation and regulation. Both of these challenges can be addressed by a new ligand-engagement
technology developed in our lab. This technology enables nucleotide-resolution capture of ligand-RNA
interactions via a high-throughput, cell-based screen of a small-molecule library versus an RNA library – the
cellular transcriptome. In preliminary work, the ligand-engagement technology has been validated with photo-
reactive probes in bacterial cells, and shown to be modular and applicable to diverse chemistries and biological
systems. The first goal of this training and research proposal is to extend the technology to human cells and to
develop chemistries that yield covalent adducts with RNA specifically at sites of RNA tertiary structures. The
second goal of this proposal is to characterize the effects of covalent modification on gene expression for a
subset of ligandable RNAs. Completion of these aims will create a concise strategy for linking small molecule
engagement with RNA to direct functional modulation of gene expression. This multi-disciplinary project
emphasizes training in the fields of technology development, RNA biology, and bioinformatics. Expertise in
these fields, combined with my previous experiences as a chemical biologist and proteomicist, will position me
at the forefront of RNA-targeted therapeutics development. I envision using this training as a launching point
for an independent career as a scientific investigator and visionary leader with a research agenda focused on
developing new technologies that modulate RNA function and impact human health.

Public health relevance
Project Narrative RNA-targeting chemistries are the foundation for new classes of therapeutics that circumvent challenges associated with protein-centered drug discovery. Numerous cellular RNAs contain functionally-important tertiary structures that may specifically engage small molecules, yet there is currently no scalable platform for identification of these sites or small molecules that specifically engage these sites. The goal of this training and research proposal is to train the applicant in and allow the applicant to create a screening and bioinformatic platform for high-throughput discovery of covalent chemistries that modulate function of human RNAs.